Regional Prospective Observational Research in Tuberculosis (RePORT) International Coordinating Center (RICC) (RePORT RICC)

The National Institutes of Health, National Institute of Allergy and Infectious Diseases (NIAID), Division of AIDS (DAIDS) supports the Regional Prospective Observational Research in Tuberculosis (RePORT) International Coordinating Center (RICC), which serves as the point of contact and the coordinating entity for RePORT International related activities. RePORT International began as a cooperative strategy between the U.S. Division of AIDS (DAIDS)/NIAID/NIH and interested governments to address the threat of tuberculosis (TB), which affects the lives and well-being of people across the globe and poses an increased risk for people living with HIV and AIDS. Each RePORT consortium is designed to support in-country data collection, specimen biorepositories, and associated research with the goal of enhancing regional research and building capacity to support worldwide TB (drug-susceptible and drug-resistant) prevention and treatment research.